BRADYKININ 2 RECEPTOR EXPRESSION IN HYPERTENSION

African Americans exhibit increased sensitivity to bradykinin compared to Caucasians. This explains the increased risk of ACEI-induced angioedema observed in African American. This study goal is to compare the cutaneous response to bradykinin between normotensives and hypertensives, African American and Caucasian and between African Americans with and without a history of ACEI-associated angioedema. Compare skin fibroblast BK-2 receptor binding characteristics and receptor gene expression between normotensiv and hypertensive subjects. Compare skin fibroblast BK-2 receptor binding characteristics and receptor gene expression between African American subjects Caucasian subjects. Compare skin fibroblasts BK-2 receptor binding characteristics and receptor gene expression between African American w/ and w/out a history of ACEI-associated angioedema.